Fundamental mechanisms causing pituitary stem cell aging in mice and humans

Project Summary
The pituitary gland produces hormones which maintain homeostasis of multiple target organs over the course
of adult life, yet pituitary cells gradually display signs of reduced cellular and biological activity as animals age.
Pituitary growth hormone production naturally declines with age in a process called the somatopause and is
very low in humans over 60 years old. Adult pituitary stem cells expressing the stem marker SOX2 comprise a
small proportion of adult pituitary cells and can proliferate and differentiate to regenerate nascent endocrine
cells after organ damage or in response to physiologic demands. The number of pituitary stem cells declines
over the course of adult life, and their ability to regenerate in response to organ damage rapidly declines with
age, becoming very limited as early as middle-age at 8-months in mice. The fundamental mechanisms
responsible for age-related loss of pituitary stem cell regenerative capacity are virtually unexplored. In this
proposal, we will utilize cutting edge genomic and in vitro technologies to elucidate pituitary stem cell gene
expression patterns over the course of aging and functionally determine which genes are required for pituitary
stem cell-mediated regeneration. First, we will combine fluorescence activated cell sorting with single-cell RNA
sequencing in order to build a sex-specific single-cell atlas of mouse pituitary stem cell transcriptomics
between the ages of 2-month-old regenerative stem cells through to 8-month-old non-regenerative stem cells.
This novel data will unveil the dynamic temporal changes in gene regulatory networks governing pituitary stem
cell behavior throughout life and identify novel candidate genes causing loss of regeneration in old pituitary
stem cells. Second, we will functionally validate the role of novel genes in pituitary stem cell proliferation and
differentiation identified from our preliminary data and single-cell atlas. We will utilize an established small
interfering knockdown assay to inhibit expression of the two candidates from our preliminary data that are
young-stem cell specific for their ability to promote stem cell proliferation and/or differentiation. We will
concurrently engineer a novel pituitary-specific fluorescent reporter gene in a human induced pluripotent stem
cell line. This indicator of pituitary commitment in organoids will facilitate transitioning future functional studies
of pituitary stem cell aging to a human in vitro model. Using these approaches, we will generate hypotheses
and test candidate genes for regulation of age-dependent pituitary stem cell regeneration. This will uncover
the molecular mechanisms enabling postnatal pituitary stem cell proliferation and differentiation. In the long
term, this knowledge will aid efforts to prolong regeneration and combat aging of pituitary cells in the elderly.

Public health relevance
Project Narrative The pituitary gland produces hormones that are required to maintain proper endocrine function throughout adult life, but organ function declines with age. In particular, pituitary stem cells lose their ability to regenerate hormone-producing cells in response to organ damage by middle age in mice. In this proposal, we will use cutting edge single-cell RNA sequencing and human induced pluripotent stem cell techniques to determine genes responsible for pituitary stem cell aging in hopes of prolonging the window of regeneration in vivo.